Aptamer therapeutic for safe and low-cost treatment of snake bite envenomation

Snake bite envenomation is a significant problem in the US and worldwide that can result in substantial morbidity and even
death. Snake venom contains a complex mixture of toxins including neurotoxins and myotoxins, as well as toxins that
disrupt normal hemostasis and can produce fatal hemorrhage. Snake venoms also include several classes of digestive and
proteolytic enzymes that are responsible for the extensive local tissue destruction from snake bites that can result in
permanent disability or require limb amputation. Current antivenom products consist of antibody fragments raised in horses
or sheep and are generally effective at stabilizing envenomation patients, however they come with several limitations in that
they are not effective against all species of N. American venomous snakes in mitigating tissue damage, and there are adverse
effects such as serum sickness, hypersensitivity, and recurrent coagulopathy. In addition, antibody-based formulations have
an extremely high cost, with the cost of the drug ranging from $20,000 to $40,000 per patient treatment.
We propose to develop a novel antivenom therapeutic based on high-affinity aptamers, which consist of single-stranded
oligodeoxynucleotides that form stem-loop structures to bind to their targets. Our proprietary X-Aptamer selection
technology utilizes bead-based oligo DNA combinatorial libraries in which certain bases contain protein-like side
modifications to enhance binding affinity. In this project, we will generate X-Aptamers against a set of major toxin classes
found in N. American venomous snakes, to develop novel antivenom formulation with a better safety profile than current
antibody-based antivenoms. Our preliminary studies have demonstrated selection of aptamers capable of neutralizing
myotoxin from Southern Pacific rattlesnakes (C. o. helleri) in a hind limb paralysis model in mice.
The project aims are: 1) Generate high-affinity oligonucleotide X-Aptamers against the five major classes of N. American
snake venom toxins and measure the dissociation constant for each X-Aptamer and its target toxin; 2) Demonstrate in vivo
efficacy of X-Aptamers against snake venom toxins and crude venom, using mouse models of hemorrhagic activity, creatine
kinase activity, hind-limb paralysis, and lethality, to determine the effective dose for each aptamer; 3) Perform dose-ranging
and toxicology studies in rats with the blended aptamer antivenom formulation. The completion of these studies will
demonstrate safety and efficacy of a novel aptamer-based formulation which will have a strong impact and market potential
in the emergency treatment of snake bite envenomation.

Public health relevance
Snake bites are a significant emergency care concern, as current serum-based antivenom products are often not effective at reducing the severe tissue damage resulting from snake venom. We propose to develop a novel antivenom therapeutic based on high-affinity aptamers, which consist of single-stranded DNA segments that form stem-loop structures to bind to their targets. Our aptamer-based antivenom formulation will be targeted to neutralize the major toxin classes found in N. American venomous snakes, to provide a safe and consistent emergency treatment for snake bites.